Development of small molecule cGAS inhibitors for repression of dsDNA-triggered interferon expression

Cyclic GMP-AMP synthase (cGAS) is the primary sensor for cytosolic dsDNA, producing the cyclic dinucleotide
cGAMP, a second messenger initiating cytokine production in subsets of myeloid-lineage cell types and
responsible for providing innate immunity. Aberrant cytosolic dsDNA contributes to inflammatory diseases,
suggesting that inhibition of cGAS may be therapeutically beneficial. We recently developed a mass-
spectrometry-based high throughput screen (HTS) using mouse cGAS and identified small-molecule inhibitors
that yielded the first active and specific inhibitors of cGAS in mouse cellular assays, albeit with no inhibitory
activity in human cells. We now developed a faster and more cost effective HTS for identification of human
cGAS inhibitors using chemiluminescence and screened 300,000 compounds. Subsequent medicinal
chemistry optimization identified potent and specific inhibitors for human cGAS active in major interferon-
producing cell types including primary macrophages and PBMCs. We have also solved co-crystal structures of
inhibitors with human cGAS, suggesting structure- and computational-guided optimization path for the lead
inhibitors. We propose to identify new hit compounds to access additional drug scaffolds through extended
drug library screening to continue supporting our medicinal chemistry program. Using the most potent and
specific inhibitors, we wish to characterize their inhibitory effect and pathway specificity in a more diverse
range of cells. Our long-term goal is to develop therapeutics for cGAS-dysregulation associated diseases.
This proposal is organized in 3 aims: (1) Identify new chemical scaffolds by HTS and apply
cheminformatic analysis and medicinal chemistry hit optimization. We will use our newly established and
validated HTS method for identification of human cGAS inhibitors to screen a newly available library of 100,000
compounds. New hit compounds will be prioritized for further derivatization to optimize potency and drug-like
characteristics. (2) Structure/computation-guided design for optimization of new scaffolds and lead
human cGAS inhibitors. We will use the insights gained from inhibitor-cGAS co-crystal structures to design,
synthesize, and test derivatives to probe for the most potent, and promising drug-like cGAS inhibitor(s). (3)
Develop new cellular validation assays for the identification of potent and highly selective cGAS
inhibitors. We propose to evaluate and validate new and recently identified inhibitors by assessing their
efficacy, selectivity, and biocompatibility using established and new cellular assays including non-myeloid
cancer cell lines with chromosomal instability, primary myeloid cells, and patient-derived myeloid cells.
Although initially discovered as central dsDNA sensor for antiviral activity, cGAS is also emerging as a player in
obesity, neurodegenerative diseases, tumorigenesis, and cancer metastasis. Well-characterized, validated,
potent, and specific cGAS inhibitors are needed in the community studying cGAS-STING biology as well as for
treating cGAS-related inflammatory diseases!

Public health relevance
While important as a central dsDNA sensor for invading pathogens, aberrant activation of the cGAS-STING pathway also contributes to autoimmune and inflammatory diseases including Parkinson's disease, as well as to chromosome-instability-driven cancer metastasis. We study the cGAS-STING innate immunity pathway and are identifying, characterizing, and validating small-molecule inhibitors of cGAS by applying a combination of high-throughput screening, biochemical, medicinal chemistry, structural, and cellular assays. !